Trans-NIH Consortium Meeting: Randomize Controlled Trials of Lifestyle Weight Loss Interventions for Genome-Wide Association Studies (August - 28-29, 2019)

Support to the NCI by Scientific Consulting Group for a Trans-NIH Consortium Meeting: Randomize Controlled Trials of Lifestyle Weight Loss Interventions for Genome-Wide Association Studies (August - 28-29, 2019)